YAP/TAZ-TEAD signaling in the vocal fold

Project Summary/Abstract
Voice disorders are the most common communication disorder across the lifespan;1 nearly 20 million
Americans report dysphonia annually at an annual cost of ~$13 billion when considering both treatment and
lost wages.2,3 Vocal fold (VF) fibrosis is a major cause of intractable voice disorders and treatment for fibrosis
is primarily empiric with only emerging biological insight to drive therapeutic decision-making. Our laboratory
and others implicated Transforming Growth Factor (TGF)-β /SMAD signaling in the development of fibrosis and
this pathway is likely an ideal therapeutic target for tissue fibrosis.4,5 However, SMAD signaling does not occur
in isolation and SMAD inhibition results in a less favorable feedback cycle, posing a significant challenge to
these targeted approaches. The Hippo signaling pathway is implicated in cell survival, differentiation, organ
development, and fibrosis.6,7 Yes-associated protein (YAP) and transcriptional co-activator with PDZ binding
motif (TAZ) have central roles in the Hippo pathway to regulate transcriptional factor activity, such as
transcriptional enhanced associate domain (TEAD) family molecules. Although the Hippo pathway is
modulated by soluble factors, cell-cell junctions, and extracellular matrix (ECM), these upstream signals are
integrated to alter YAP/TAZ activity.8 Other signaling pathways activated in parallel with YAP/TAZ activation
are integrated into the YAP/TAZ-TEAD system via direct and indirect interactions with the YAP/TAZ-TEAD
complex.9,10 Since multiple pathways, including fibrotic signaling, require concurrent YAP/TAZ activation, the
YAP/TAZ-TEAD complex has emerged as an attractive therapeutic target for a variety of diseases.10,11
Interestingly and of particular relevance to the VFs, tissue stiffness is a primary regulator of the Hippo
pathway.12,13 Stiff ECM associated with the accumulation of highly cross-linked, fibrous ECM promotes
YAP/TAZ activation. Conversely, soft ECM suppresses YAP/TAZ activity. Since tissue viscoelasticity is critical
for VF function, we hypothesize Hippo signaling in the VFs contributes to organ-specific development, growth,
and maintenance. Multiple signaling pathways related to fibrosis, including SMAD, Wnt, and Rho interact with
the YAP/TAZ-TEAD complex and we recently reported YAP/TAZ activation mediated the fibrotic response
stimulated by TGF-β/SMAD signaling in human VF fibroblasts.11,14,15 Based on our preliminary data and known
Hippo functions, we hypothesize Hippo signaling is critical for development, growth, and maintenance of VF
tissue. And in the context of VF injury, the activation of YAP/TAZ-TEAD signaling contributes to the fibrotic
response due to altered tissue viscosity. The current proposal seeks to reveal the roles of YAP/TAZ-TEAD
signaling associated with fibrotic responses in VF fibroblasts and laryngeal tissue formation using a fibroblast
culture model, rat VF injury model, and gene-modified mouse. Data obtained from this study will provide a
foundation for the development of new treatment approaches to be investigated in future clinical trials.

Public health relevance
Project Narrative Current therapeutics for vocal fold fibrosis are largely empiric and outcomes are inconsistent, potentially due to emerging insight into relevant molecular and cell-based events. This proposal aims to address the roles of YAP/TAZ-TEAD signaling that putatively involves in both vocal fold fibrosis and tissue formation. Data acquired under this proposal will add to the emerging body of literature regarding biochemical phenomena, potentially leading to development of new treatment approaches.